CLINTRUSC_PD Core

PD CORE - PROJECT SUMMARY
The Professional Development (PD) Core is a pivotal resource tailored for educational, training, and mentoring
services targeted at researchers within CLINTRUSC. This centralized hub aligns with the core aims and
objectives of CLINTRUSC, aiming to advance Clinical and Translational (C&T) studies at USC. The PD Core
operates under three key aims: (1) Advancing Grantsmanship, which focuses on fortifying the pursuit of
external funding for C&T research. It supports P&D awardees, identifying funding opportunities, refining study
designs, and engaging in the annual USC PROPEL Research & Mentorship Program. (2) Fostering
Transdisciplinary Research, which aims to cultivate collaborative and transdisciplinary research teams. The PD
Core collaborates with other cores to ensure adequate training, skills development, and project mentorship. (2)
Mentoring, Monitoring, and Post-Award Development, which emphasizes ongoing mentorship and monitoring
for P&D awardees, including workshops, periodic assessments, and consistent progress tracking. These
initiatives are synthesized with other CLINTRUSC cores and aim to equip C&T awardees with the skills and
networks required for successful integration of novel transdisciplinary research into federal funding, fostering
continuous growth and success within the field of C&T research.